The role of extracellular vesicles in septic encephalopathy metabolism and immunity

Project Summary/Abstract: Septic encephalopathy (SE) constitutes a common form of encephalopathy with
an associated 70% mortality rate, underscoring the need for a highly effective treatment. The pathophysiology
of SE is linked to an energetic crisis in the brain combined with immune-mediated neuro-inflammation.
Specifically, neural cells shift their energy generation from aerobic oxidative phosphorylation (OXPHOS) to less-
efficient glycolysis. Energy deficiency in the brain leads to excess accumulation of reactive oxygen species
(ROS) and subsequently to oxidative stress, inflammation, and neuronal cell death. Studies have highlighted a
mesenchymal stem cell (MSC)-related improvement in energetics that is partially achieved by the transfer of
bioactive molecules such as miRNAs and proteins carried by secreted extracellular vesicles (MSC-EVs). In our
preliminary work using a murine model of SE, we showed that MSC-EVs administered intravenously restore
cerebellar ATP and improve neuro-inflammation and Purkinje and granule cell viability. However, the
mechanisms by which MSC-EV cargo exerts its protective effects on neuronal integrity in SE have not been
studied. The goal of this application is to examine the therapeutic potential of MSC-EVs in SE using a mechanistic
approach to connect EV cargo with the regulation of metabolic and immune pathways. By including a murine
model of SE, we propose to examine whether specific members of the MSC-EV cargo (miRNAs and proteins)
alter metabolic and immune pathways, leading to improved neuronal cell viability. We hypothesize that in SE,
based on our previous work, MSC-EV cargo directly activates cerebellar OXPHOS-related and other metabolic
pathways, improving ATP generation, neuro-inflammation, and neuronal cell death. We will study in vivo the
MSC-EV mechanism of action by using inhibitors of MSC-EV miRNA and protein cargo members that are
abundant in the utilized EVs. The practical implication of this effort includes the development of EV-based
therapeutic protocols to alleviate the metabolic and immune abnormalities that can broadly affect neural cells in
encephalopathy and other conditions that cause brain injury. The PI is firmly committed to a career in translational
neuroscience research and his goals are strongly supported by his institution and the co-Is. He is currently a
tenure-track Assistant Professor of Pediatrics with 75% protected time for research and recently funded by
K12/STTR grants, and Children’s National Hospital has been providing him with bench and office space, and
computer/software support. The current proposal includes a comprehensive research plan that will advance our
knowledge in EV therapeutic properties using techniques such as liquid chromatography and mass spectrometry,
ATP measurement using Seahorse© technology, RNA/miRNA sequencing and advanced cerebellar
histopathology. This work will lead to an R01-level grant focusing on SE metabolism and EV therapeutics using
MSC-EVs and more efficient engineered EVs.

Public health relevance
Project Narrative/Public Health Relevance: Septic encephalopathy is linked to inflammation and the brain’s inability to produce enough energy and is associated with a 70% mortality rate due to the lack of effective treatments. Using septic mice treated with mesenchymal stem cell-derived structures called extracellular vesicles, this study aims to advance our understanding on how these extracellular vesicles change immune and metabolic pathways involved in septic encephalopathy and improve cellular death and clinical outcomes. The findings from this effort will allow us to develop new therapeutic protocols and use this treatment in other encephalopathies and neurological conditions that cause brain injury and have long-term devastating effects.